Commercialization Readiness for a Portable PET Insert System for Simultaneous TOF-PET and MR Brain Imaging

Project Summary
Neurological and mental health disorders cost the United States more than $800 billion each year. Alzheimer’s
disease (AD) alone costs the U.S. an estimated $345 billion in 2023. The recent approval of anti-amyloid
treatments for AD underscores the urgency for early diagnosis. Accurate diagnosis of various neurological and
mental health disorders, including brain tumors, epilepsy, Alzheimer’s disease, and depression, often requires
both PET and MRI scans, typically involving separate PET/CT and MRI procedures. This sequential approach
not only causes patient inconvenience and delayed diagnosis, but it also leads to image fusion error and
additional radiation exposure from the CT scan. Hybrid PET/MRI systems, capable of simultaneous PET and
MRI scanning, present a solution to these challenges. However, their adoption is hindered by the prohibitive
costs of current permanently-integrated systems, which includes approximately $5 million for purchasing the
system, plus an additional $1.5-2 million for room renovations. In the U.S., only about 60 integrated PET/MRI
systems are in use, compared to 13,500 MRI systems. Existing whole-body PET/CT and PET/MRI systems are
also limited in spatial resolution and photon sensitivity needed for brain imaging. PETcoil is addressing these
challenges by commercializing a portable, brain-dedicated PET system that can be inserted into (and removed
from) any MRI system to lower the cost to achieve simultaneous PET/MRI by 10-fold compared to current
permanently-integrated PET/MRI system. The PETcoil insert system also achieves over 3 times higher photon
sensitivity and over 4 times finer volumetric spatial resolution over current PET/MRI systems, enhancing lesion
detection and quantification in brains. In Phase II, we developed a functional PET insert prototype. The current
CRP program focuses on optimizing the design for mass production and preparing for regulatory submission,
with three specific aims: (1) Collaborate with a product development firm to finalize the industrial design and
manufacturing process for the production unit. (2) Verify and validate the safety and performance of the
production unit for regulatory submission in collaboration with Stanford University. (3) Work with a seasoned
consultant to develop a regulatory strategy and prepare for the FDA submission. This includes holding pre-
submission meetings with the FDA, compiling the required materials, and submitting the regulatory application.
This CRP program will culminate in a production-ready brain PET insert, set for manufacturing and regulatory
submission, poised to enable widespread dissemination of PET/MRI technology for characterizing neurological
and mental health disorders.

Public health relevance
Project Narrative Neurological and mental health disorders, including Alzheimer's disease, pose a significant financial burden on the U.S. healthcare system, costing over $800 billion annually. This Commercialization Readiness Pilot program supports the commercialization of a cost-effective, brain-dedicated, and portable positron emission tomography (PET) scanner for use as a stand-alone system or with existing MRI systems. The product developed under this program can make brain PET and combined PET/MRI imaging more widely available, potentially improving early diagnosis and treatment of neurological and mental health disorders.